Training for Clinician Scientists in Imaging Research

The goal of our proposed plan is to renew and improve a highly successful 10 year training program to
develop in clinician scientists the ability to employ imaging techniques to the investigation of medical disorders
in a wide spectrum of medical disciplines. The proposed program will continue to correct the current dearth of
clinicians who are able to utilize the state-of-the-art tools available to enhance imaging for applications in
radiology and other specialties. The proposed program will increase the ongoing participation of trainees and
mentors in radiology and nuclear medicine, as well as internal medicine, neurology, neuropathology,
oncology, pediatrics, psychiatry, and surgery, with future trainees and mentors from anatomical pathology,
orthopedics, and urology in this renewal. The prior 5 years were funded by NIBIB (primary), NIDA, NIDDK,
and NIAAA, and will now be expanded by NIA and NIMH, for a total of 6 slots per year for 5 additional years.
The current and future program will provide training in structured rigorous research for non-faculty residents
and post-doctoral fellows in the participating departments and divisions in the School of Medicine (SOM). The
proposed program will be directly integrated with existing, more advanced training programs, including MS
and PhD degree granting programs in clinical investigation, through the Graduate Training in Program in
Clinical Investigation, a joint program of SOM and School of Public Health (SPH), as well as opportunities in
basic science, engineering, and SPH programs. The overall goals of the proposed program are: Aim 1. To
provide 1-2 years of intensive research training to radiology trainees to develop into clinician scientists
pursuing careers in imaging research. Aim 2. To provide 1-2 years of intensive research training to trainees in
other specialties to pursue research careers utilizing imaging methodologies in their future research careers.
By starting early in their careers, the physician trainees will continue to pursue careers in
preclinical/clinical investigations incorporating imaging technologies. The success of our approach is
confirmed by the fact that 76% of our prior trainees over the past decade continue in research careers. The
ultimate outcome will be increased numbers of physicians who will carry out a research career integrated with
both basic and applied imaging approaches.
During the T32 training years, the trainees will work closely with carefully assigned mentors from
radiology and their home department (if outside radiology) and laboratories, with faculty drawn from not only
radiology, but also over 11 associated departments and divisions in the SOM, plus biomedical and electrical
engineering, computer sciences, informatics, psychology, and SPH. Evaluation will consist of formal
progress reports, mock grant preparation and review, publications, and required national presentations,
including biannual T32 meetings in Bethesda. The long-term goal is to attract physicians into an academic
career employing imaging research as a major component of their future research.

Public health relevance
This is a competitive renewal for an additional 5 years of a decade long unique T32 program specializing in 1-2 years of research training in imaging for resident and fellow physicians from Radiology and several departments. The long term goal is to develop the next generation of Physician imaging scientists.